The Young Empowered Scientists for ContinUed Research Engagement (YES for CURE) Program at the Dana-Farber/Harvard Cancer Center (DF/HCC)

YES for CURE Project Summary
Increasing the participation and retention of underrepresented minorities in cancer-related STEM fields is
critical for eliminating cancer disparities and improving cancer outcomes. Early engagement in scientific research
has been linked to enrollment and retention of students in STEM degree programs and careers. To address the
disproportionately low numbers of URMs and socioeconomically disadvantaged individuals engaged in cancer
research related careers, the Dana-Farber/Harvard Cancer Center requests funding to support the Young
Empowered Scientists for ContinUed Research Engagement (YES for CURE) Program, a multi-year, holistic,
innovative, and comprehensive cancer and cancer disparities research and education program for high school
and undergraduate students in the Boston area. Students will participate in research training, professional skills
development, career exploration, scientific curriculum, and community engagement programming.
The goal of the YES for CURE Program is to engage the scientific curiosity and promote the academic
success and future research careers of promising young scientists from underrepresented communities
and, by doing so, equip our scholars with knowledge and insight to become ambassadors in their
communities. The aims of the program are: 1) To engage talented and highly motivated high school and
undergraduate URM students in mentored, hands on, cancer research experiences culminating in a presentation
of their independent project. 2) To build student’s knowledge of the key concepts, decision making processes,
and skills necessary for academic and professional success through participation in a year-round curriculum. 3)
To develop a supportive, informed, and engaged community of culturally competent cancer scientists and
science enthusiasts comprised of alumni, mentors, families, and community partners who will nurture and
empower program participants. Scholars will develop and implement science and health outreach programs at
middle schools that will contribute to scholar’s self-identification as competent scientific learners.
The YES for CURE Program will strive to excel in seven measurable objectives:
1. Each summer 34 students (17 per cohort) will participate in a full-time cancer research experience.
2. YES for CURE scholars will increase their knowledge of career paths and concepts and topics in
cancer research, developing skills in research practices, analytical thinking, presentations, and ethics.
3. YES for CURE scholars and families will enhance their awareness of STEM research and education.
4. Scholars will develop and implement STEM curricula in their own communities.
5. YES for CURE Scholars will graduate informed and ready to progress in their STEM training.
6. At least 85% of YES for CURE participants will complete an undergraduate degree in STEM.
7. At least 50% will pursue graduate school and careers in a cancer, cancer disparities, or STEM field.

Public health relevance
YES for CURE Project Narrative Increasing the participation and retention of underrepresented minorities (URMs) in cancer-related STEM fields is critical for eliminating cancer disparities and improving cancer outcomes in the United States. Early engagement in scientific research has been linked to enrollment and retention of students in STEM degree programs and careers. The Young Empowered Scientists for ContinUed Research Engagement (YES for CURE) Program, in the Dana-Farber/Harvard Cancer Center, is a multi-year holistic and comprehensive cancer and cancer disparities research experience and education program for URM high school and undergraduate students in the Greater Boston area.